Switchable Organometallic Catalysts for Organic Reaction Development

The discovery of new catalyzed methods to generate key bonds in organic molecules is vital to the sustainable synthesis of biologically relevant molecules. The rapid diversification of simple chemical scaffolds using automated parallel synthesis technologies allows for the generation of chemical libraries to screen for new biological activity, and to assess structural-activity relationships, which facilitates the design of novel medicinal targets with improved activity. New catalytic methods for parallel synthesis benefit from catalysts that can selectively functionalize one site on the chemical scaffold, without changing other reactive functionalities on the molecule. Developing a single catalyst that can select one reactive functionality, and then be switched to select and react at a different site on the molecule, will allow sequential control of iterative reactions, thereby building advanced synthetic targets in one pot using a strategy amenable to automated technologies. The proposed work is centered on developing an organometallic catalyst with site-selective reactivity that can be switched by the irradiation of different wavelengths of visible and ultraviolet light. The optimized organometallic catalysts will be applied to iterative one-pot cross-coupling technologies, selectively activating either C(sp2)-X or C(sp3)-X bonds for the formation of new carbon-carbon bonds depending on the external light stimulus. Investigation of the ability of the switchable organometallic complex to undertake hydrogen-atom transfer from bound alcohols will also be conducted, resulting in the oxidation of the alcohol in situ for subsequent reductive cross-electrophile coupling strategies. This approach facilitates temporal control of the rates of the multiple catalytic cycles according to the wavelength of the light irradiation and will be applied to the coupling of alcohols with a range of different electrophilic species. These methodologies will enable the iterative formation of key biological motifs, such as stereodefined polyol sequences, that can be used to study novel medicinal targets. The program will also train a group of graduate students, undergraduate students, and postdoctoral researchers in scientific research encompassing organic, organometallic, and physical organic chemistry, and will provide these colleagues with the professional development necessary to ensure success in their future careers.

Public health relevance
Project Narrative This program centers on developing new organometallic catalysts that can selectively activate different groups on organic molecules according to the wavelength of light irradiation. This will allow for the iterative synthesis of biological targets in one-pot, facilitating rapid access to chemical libraries for medicinal screening and the optimization of biological function. The new technologies developed in the formation of carbon-carbon bonds will also be amenable to automated synthesis platforms of use in medicinal chemistry laboratories.